2023 Red Cells Gordon Research Conference

Project Summary
We seek funding for the 2023 Red Cells Gordon Research Conference (GRC), which will be held on June 4-9 at
Salve Regina University in Newport, RI. The Red Cells GRC was initiated in 1979 and is an international forum
for the presentation of the latest unpublished data on erythroid biology. It brings together a diverse community
of researchers from academia, government and industry at all levels of expertise from trainees to senior
investigators. It provides a unique environment for the discussion of research and opportunities for trainee
professional development through panel discussions with mentors from academic institutions, industry and
granting agencies. The Gordon Conference format provides a relaxed atmosphere at a collegial venue where
researchers from all areas of erythroid biology can interact and develop interdisciplinary collaborations. The
venue for the 2023 GRC, Salve Regina University in Newport, RI, is conveniently located about 74 miles from
Boston's international airport. The Red Cells GRC has a long history of showcasing innovative cutting-edge
research into erythroid biology. Remarkably, many of these results have proven to become widely applicable to
all areas of biology and medicine. The success of this meeting is due to the informal GRC atmosphere that
promotes social as well as intellectual interactions that lead to novel collaborative science. Topics for the 2023
Red Cells GRC include developmental erythropoiesis and stem cell biology, which includes the use of ES and
iPS cells to study erythroid development. Analysis of the mechanisms that regulate normal and perturbed
erythroid progenitor cell development and terminal differentiation, the interplay between iron transport and
utilization and the effects of infection and inflammation of erythroid output and updates on the unique cell biology
of the erythrocyte membrane cytoskeleton will also be discussed. The conference will feature sessions that
highlight new methods for single cell analysis in erythroid biology and the regulation gene expression by
transcription factors, epigenetics and chromatin architecture. The conference will complement these sessions
with discussion of emerging treatments and therapies for erythroid disorders. In addition, we will have two
distinguished keynote speakers, Len Zon and Merav Socolovsky, who will highlight recent advances in the field.
The meeting will also feature programing targeted to trainees and junior investigators, and provide unique
opportunities for meaningful interactions between trainees and established investigators. Overall, the Red Cells
GRC serves an import mission to the NIH by promoting research into erythroid biology, which will lead to new
and improved treatments for erythroid disorders and by enhancing the recruitment of new researchers in the field
through support, encouragement and exposure to innovative research.

Public health relevance
Project Narrative The Red Cells Gordon Research Conference (GRC) provides an ideal venue for the presentation of unpublished innovative research on erythroid biology by established investigators and trainees. The sessions will focus on molecular and cellular aspects of normal and perturbed erythropoiesis, pathophysiology of erythroid diseases and emerging therapies to treat erythroid disorders. The primary goal of the GRC is to bring together a diverse research community and provide a forum to discuss and establish new collaborations for interdisciplinary research and the development of new therapies to treat patients.